Neurophysiology of Working Memory Maturation in Adolescence

PROJECT SUMMARY
The goal of this project is to investigate the neural substrates of the maturation process that
takes place around puberty and which is associated with the development of a key cognitive
ability, working memory. The prefrontal cortex, a part of the brain greatly expanded in primates
compared to other vertebrates, undergoes a long maturation process that extends through
puberty and into early adulthood. This process mirrors the development of higher cognitive
functions. A number of mental illnesses have onsets linked to the maturation of the prefrontal
cortex, most notably schizophrenia, which manifests itself in early adulthood. Executive function
also improves in adulthood, and inadequate development of this capacity is associated with
delinquency and other conditions of health and social significance. Little is known about the
physiological changes that the prefrontal cortex undergoes in adolescence so as to mediate
increased cognitive control. Taking advantage of recent methodological and conceptual
advances, we propose to investigate the changes of prefrontal cortical physiology that occur
after puberty. We propose to use a non-human primate model that will allow us to conduct
neurophysiological recordings in the prefrontal cortex of peri-pubertal and adult animals. Our
study will make use of monkeys trained to perform behavioral tasks that test working memory
ability. Experiments will record neuronal activity related to task performance to understand what
neural variables maturate after the onset of puberty. These experiments will offer insights on
how development of the prefrontal cortex alters its physiological responses, findings that will be
essential for understanding and treating mental illnesses thought to be associated with a failure
of prefrontal cortical maturation.

Public health relevance
PROJECT NARRATIVE The proposed research will determine how the functions of prefrontal cortex neurons change between adolescence and adulthood. Knowledge drawn from these experiments will elucidate the development of higher cognitive processes such as working memory, which is necessary for understanding the biological basis of conditions such as Attention Deficit Disorder and mental illnesses such as schizophrenia.